Translational Research in Functional Vision and Accessibility

PROJECT SUMMARY/ABSTRACT
This proposal requests partial support for a conference on the state of the art in translational research and its
application to functional vision for the visually impaired and accessibility for the blind. The conference is
organized by the scientists at the Smith-Kettlewell Eye Research Institute and will take place August 3-4, 2023
in San Francisco, CA. In keeping with the unique theme of this conference centered on translational research
to optimize functional vision and accessibility, our aims include integrating multi-disciplinary approaches to
evaluating visual dysfunction and its consequences. A second aim is to bring stakeholders (those experiencing
vision loss and blindness) and those doing translational research (scientists, clinicians, and inventors) to
prioritize future research directions for diagnosis and treatment/interventions. A special feature of this
conference will be to consider the spectrum from visual impairment to blindness and evaluate the relative
merits of maximizing residual vision, visual restoration and the use of remaining senses for accessing
information from the environment. The program will include 6 sessions, and 1 double-length session, over two
days, with a total of 40 speakers. Each session will include a range of speakers from established researchers
to junior investigators, including multiple stakeholders. Diversity and inclusion will be prioritized to include
women, individuals with disability and underrepresented minorities. Each session will end with a discussion
between scientists, clinicians and stakeholders, moderated by a Smith-Kettlewell scientist. All talk sessions
will have accessible presentations to allow full participation by visually and hearing-impaired attendees. We
plan to make the oral presentations hybrid to maximize the reach of this conference and offer 20 travel
fellowships to encourage trainees to attend. Poster sessions will facilitate scientific exchange and mentoring
among participants. In sum, this unique conference brings together multidisciplinary, cross-cutting approaches
to address the multiple causes of vision dysfunction and current treatment modalities, as well as a holistic
approach to evaluating the best interventions to maximize interaction with the environment among the blind
and visually impaired.

Public health relevance
HEALTH RELEVANCE A conference on translational research that addresses visual dysfunction and improved accessibility in blindness is both timely and necessary to prioritize research directions for the future. The proposed conference will showcase the current state of the art in the field and bring together scientists, clinicians, and individuals with low vision or blindness to so that scientists can hear directly from stakeholders about the challenges they face.